A Scalable Primary Cortical Tri-Culture Model to Study the Influence for Gut Microbiome-Derived Bioactive Compounds on Neuroinflammation

PROJECT SUMMARY
Bioactive compounds produced by native or transient members of the gut microbiota are finding increasing use
as therapeutics for a variety of complex human diseases, including obesity, diabetes, cardiovascular disease,
and neurological disorders. Once these compounds cross the blood-brain-barrier, some can result in beneficial
(e.g., anti-inflammatory, neuroprotective) or detrimental (e.g., pro-inflammatory, neurodegenerative) effects on
the central nervous system (CNS). Specific cell types in the CNS are involved in this process, yet how the
bioactive compounds interact with them remains poorly understood. Cell culture models offer better experimental
control and scalability than animal models and avoid the limits of working with different species. However, most
in vitro models suffer from low biological relevance in part due to not being able to simultaneously contain the
critical cell types (i.e., neurons, astrocytes, microglia). There is a need for scalable in vitro models that can
capture phenomenological outcomes of bioactive compound-CNS interactions and alterations to neural function
observed in vivo and thus allow further mechanistic studies, bioactive compound discovery, and translation to
human use.
To address this critical need, we will employ a novel primary rat cortical cell tri-culture (primary neuron, astrocyte,
microglia) model of neuroinflammation and integrated extracellular recording electrodes. In contrast to the co-
culture of just neurons and astrocytes, the tri-culture model more faithfully captures neurotoxic and
neuroprotective features observed in vivo. Since the tri-culture model is maintained simply by including IL-34,
TGF-β, and cholesterol supplements in the conventional co-culture media, it is amenable to scale-up and
screening studies in multi-well formats. In the proposed project, we will use the tri-culture model to simulate
neuroinflammation that is present in many disorders that range from cancer to neurodegeneration. Microglia
plays a particularly important role in neuroinflammation, where various phenotypic changes are observed,
including impaired phagocytic capacity. Here, we will use a lipopolysaccharide (LPS)-induced neuroinflammation
model. By introducing the bioactive molecules, before, during, or after LPS treatment, we will further mimic
scenarios such as the normal presence of gut microbiota bioactive molecules (e.g., prevention) vs. their post-
symptom introduction (e.g., therapeutic). Across two aims, we will reveal the effects of bioactive compounds on
neuroinflammatory responses via morphological, and proteomic read-outs, as well as on cellular function by
evaluating microglial phagocytic capacity and neuronal electrophysiological activity. We expect that this project
will create a scalable in vitro tool to study the influence of gut microbiome-derived bioactive compounds on
neuroinflammation. This tool can then be used broadly for mechanistic studies and for discovering new bioactive
molecules that inform regular diet or prescribed as therapeutics for improving and maintaining neurological
health.

Public health relevance
NARRATIVE Bioactive compounds produced by native or transient members of the gut microbiome are finding increasing use as therapeutics for a variety of complex human diseases, including obesity, diabetes, cardiovascular disease, and neurological disorders. In this project, we employ novel neural culture model of inflammation, coupled with electrophysiological recording capabilities, to provide insight into the influence of gut microbiome- derived bioactive compounds on neuroinflammation. We expect that this project will create a scalable in vitro tool that will allow further mechanistic studies, bioactive compound discovery, and translation to human use.